ACTIVE VS PASSIVE TILT TEST &RELATION TO ANXIETY TRAITS IN CHILDREN

The purpose of this study is to incorporate the physiological measures of blood pressure, heart rate, cardiac output (CO), total peripheral resistance (TPR), and psychosocial factors (e.g., chronic stress and anxiety indices) and to examine the specificity of active and passive orthostatic testing and changes in cardiovascular hemodynamics in children. We will also assess the test- retest reliability of active and passive orthostatic testing outcomes over a 6-month period.